Kilohertz Frequency Alternating Current Spinal Cord Stimulation for Chronic Pain Relief

? DESCRIPTION (provided by applicant): Chronic pain is the most prevalent health problem worldwide and is often inadequately treated. Spinal cord stimulation (SCS) is a widely used, non-destructive, reversible therapy for treatment of chronic pain, particularly used when other conservative modalities have failed. Recently, the use of kilohertz frequency alternating current (KHFAC) SCS has shown potential for significantly improved outcomes, but conflicting results have been reported. KHFAC has been shown to produce a rapid and reversible conduction block in peripheral nerves. Preliminary evidence suggests that KHFAC SCS may produce pain relief without concomitant paresthesia (unlike conventional SCS), and thus significant excitement has been generated regarding this new modality. However, the mechanism by which KHFAC SCS might produce pain relief, and the differences between the neural response at kilohertz frequencies compared to conventional SCS, are poorly understood. We hypothesize that KHFAC SCS, as currently implemented, does not produce a block of neural activity but rather acts to modulate ongoing neural activity. The critical factors that determine the action of KHFAC SCS begin with the details of the technology itself, extend through its action on the spinal cord, and ultimately to the conscious perception of pain. Through the aims in this study, we anticipate demonstrating the mechanisms underlying the early clinical success (and failures) of KHFAC SCS, thus providing critical information for the field of neuromodulation. We further hypothesize that the unique features of KHFAC, which include the capacity to activate, block, and modulate activity in neural structures, could be fully exploited by the development of novel KHFAC SCS systems designed specifically to take advantage of these features. Such a system could have a significant impact on SCS clinical outcomes and responder rates. KHFAC SCS may represent one of the most exciting advances in the field SCS over its 40 year history. If successful, this project will provide the foundation for a new an powerful modality for the treatment of refractory chronic pain.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic pain is a significant problem that is often incompletely or inadequately treated. One method for treating chronic pain is the use of spinal cord stimulation (SCS). Recently the use of kilohertz frequency alternating current (KHFAC) with SCS has been evaluated, with conflicting clinical results. The goal of this project is to evaluate the effect of KHFAC on the spinal cord, understand the mechanisms by which this method might produce pain relief, and explore novel designs for SCS technology that take advantage of the unique features of the effect of KHFAC on the nervous system, with the goal of improving the pain relief obtained from SCS.